Multifunctional Nanoplatforms-Based Capture and identification of Circulating Tumor Biomarkers for Early Diagnosis of Lung Cancer

Significant disparities in incidence and mortality rates for lung cancer are reported
among ethnically and racially diverse population. African Americans suffer from lung
cancer more than any other population. High mortality rate in lung cancer is due to
being diagnosed at a later stage, where treatment options are limited. Our long-term
goal is to lay the groundwork for developing novel nanoplatform based device which
will provide a more accurate determination of the circulating cancer biomarkers from
lung cancer patients in blood screening facilities. The objective of this proposal is to
design magnetic-fluorescence multifunctional nanoplatform based device to capture,
isolate and detect circulating tumor cells (CTCs) and tumor derived exosomes from
blood samples in lung cancer patients and to establish correlations of these findings
with survival. Our central hypothesis is that bio-conjugated multicolor fluorescence
carbon dots attached magnetic nano-platform can be used to capture multiple types
of CTCs and circulating exosomes from blood samples, and as a facile multicolor
fluorescence probe for accurate identification of circulating biomarkers. The central
hypothesis will be tested by pursuing two specific aims: 1) Developing fluorescence-
magnetic nanoplatform for capture, and identification of multiple types of CTCs from
lung cancer patient blood and 2) Capture and identification of tumor derived
exosomes using nanoplatform and demonstration of clinical applications. The
proposed research is significant, because with high sensitivity and real-time
detection possibility, CDs attached magnetic nano-platform will be highly promising
for detection and identification of several subpopulation types of CTCs and
exosomes. The proximate expected outcome of this work is improving the capability
of identifying multiple clinically relevant blood based biomarkers in blood screening
facilities.

Public health relevance
The incidence of lung cancer is disproportionately higher for African American population. Long-term goal of the project is developing a novel nano-platform with capability of early diagnosis of lung cancer. This research aligns with the NIMHD’s vision of “eliminating health disparities”.